Components of selection history and the control of attention

PROJECT SUMMARY/ABSTRACT
Attention selects which aspects of sensory input receive cognitive processing and thereby influence
behavior. Drug addiction alters the attentional system, resulting in prominent attentional biases towards drug
cues. Such drug-related attentional biases are related to the broader phenomenology of addiction, including
craving and relapse. There has been long-standing interest in implementing attentional bias measures in
clinical settings, either as a predictive measure to inform treatment decisions or as a target of treatment.
However, a major barrier to the realization of this goal is that current means of assessing these biases are not
sufficiently precise to support clinical utility, which has stifled progress in this area. Mirroring this complexity,
and underscoring the need for clarity, debate has arisen concerning the role of learning history in the guidance
of attention more broadly. Persistent attentional biases have been linked to reward history, learning from
aversive outcomes, and outcome-independent selection history (e.g., familiarity). Emerging accounts of such
experience-dependent attentional biases disagree about the nature of the underlying mechanism(s) involved. If
we do not understand the variety of influences of learning history on attention at a fundamental level, how can
we understand how these influences contribute to addiction-related attentional biases? The proposed research
directly addresses this need by identifying, isolating, and measuring multiple hypothesized components of the
attentional biases that characterize addiction, providing the precision necessary for more accurate predictions
of patient outcomes and more targeted efforts to improve these outcomes through attentional bias modification.
Specific Aim 1 will distinguish between common and distinct attentional priority signals arising from reward
learning and reward-independent selection history, probing both the cognitive and neural mechanisms
underlying each of these sources of priority. Specific Aim 2 will identify the cognitive profile and neural
mechanisms underlying attentional biases attributable to aversive conditioning, which together with Specific
Aim 1 will provide a comprehensive picture of the multifaceted nature of experience-dependent attention. The
overarching goal of the proposed research is to characterize multiple distinct components of experience-dependent attentional bias that contribute to attentional biases evident in drug-dependent individuals. These
fundamental components of attentional bias will provide a much more precise window into the attentional
processes that are relevant to our understanding of addiction than existing measures can offer. It is anticipated
that the knowledge gained from the proposed research with provide a foundation for overcoming fundamental
limitations in the clinical utility of attentional bias measures, allowing for fruitful exploration of this aspect of
addiction in the context of improving assessment and treatment.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to better understand how what we pay attention to can be biased by past experience. Difficulty ignoring previously rewarding stimuli that conflict with current goals can be maladaptive and lead to undesired behaviors, as in relapses into addiction. Understanding how and why these disruptive attention patterns develop and persist holds promise in providing insights that will lead to more effective treatments for addiction and strategies aimed at preventing relapse.